Targeting Epigenetic Heterogeneity to Improve Lung Cancer Immunotherapy Response

PROJECT SUMMARY
Immunotherapies, particularly those that inhibit the PD1/PD-L1 interaction and drive T cells to recognize
and kill tumor cells, have shown striking responses in a small subset of late stage, treatment refractory squamous
lung tumors. However, the majority of patients do not have a lasting response. One way to boost response is to
include an epigenetic inhibitor, such as one targeting the Polycomb Repressive Complex 2 (PRC2), to influence
the tumor cell and microenvironment heterogeneity. Our central hypothesis is that EZH2 inhibitors will boost
immunotherapy response in squamous tumors, both by increasing immunogenic PD-L1 expressing cells
and by depleting immunosuppressive tumor associated neutrophils. The overarching goal of the proposed
study is to validate combining EZH2 inhibition with PD1/PD-L1 targeted immunotherapy and learn the molecular
mechanisms when the treatment is successful as well as when it is not successful.
In Aim 1, we will use both mouse models and human patient derived organoid cultures to examine NGFR,
CXCL9/10/11, PD-L1 and MHC expression in lung SCC cells after EZH2 inhibitor treatment. The epigenetic and
transcriptional consequences of EZH2 inhibition on squamous and bronchiolar lung tumor cells will be assessed
by ChIP-seq and RNA-seq. In Aim 2, we will focus on the tumor associated neutrophils (TANs). We will compare
TANs from placebo treated mice to those from EZH2 inhibitor treated mice for abundance, migration capacity
and ability to suppress T cells. We will also use an EZH2 conditional knock-out mouse model to further
characterize how EZH2 loss affects TANs. Again ChIP-seq and RNA-seq will be used to dissect the molecular
changes driven by EZH2 inhibition in the neutrophil populations. In Aim 3, we will treat immune-competent
squamous lung cancer bearing mice with the EZH2 inhibitor GSK126 or EPZ-6438 (Tazemetostat), and the
immunotherapy PD-1 antibody and follow tumor growth by magnetic resonance imaging. We will characterize
tumor phenotypes in responders and non-responders and examine tumors that develop acquired resistance to
this therapeutic drug combination. We will also develop tumoroid ‘multi-cultures’ containing tumor cells,
mesenchymal cells, T cells and myeloid cells to be able to test responses of systems to EZH2 inhibition and anti-
PD1 inhibition ex vivo. Completion of these aims will solidify the efficacy of a promising therapeutic combination
and uncover mechanisms by which tumor hierarchies and microenvironments are changed by EZH2 inhibitors
in squamous lung cancers. Given that one arm of a Phase 1/2 clinical trial combining EZH2 inhibition with anti-
PDL1 just began recruiting late stage non-small cell lung cancer patients, learning the phenotypes and
mechanisms of responders and non-responders will be extremely timely for any Phase 2/3 trials that ensue.
1

Public health relevance
PI: Brainson, Christine Fillmore PROJECT NARRATIVE Lung cancer is the leading cause of cancer-related deaths worldwide, and is a very complex disease with different cell types that comprise each tumor. Immunotherapy is ground-breaking because it is able to cure some patients with late stage tumors, but the number of patients that have this great response is still low. In this proposal, we will test the combination of a second drug with immunotherapy to increase the likelihood that squamous lung tumors will respond to treatment.